Dopaminergic regulation of prefrontal activity patterns during behavior

PROJECT SUMMARY / ABSTRACT
Dopaminergic projections from ventral tegmental area (VTA) to medial prefrontal cortex (mPFC), underlie
critical functions disrupted across many neuropsychiatric conditions. However, the circuit-level mechanisms by
which prefrontal dopamine modulates specific behaviors remain poorly understood. The scientific objective of
this project is to determine how particular patterns of neural activity relate to distinct behavioral states and how
prefrontal dopamine alters these patterns to influence behavior.
My preliminary studies have shown that activating dopamine D2 receptors (D2Rs) in prefrontal brain slices
enhances a positively correlated activity state. D2Rs are preferentially activated by the high dopamine state
induced by phasic bursting of VTA neurons. I find that phasic, but not tonic stimulation of VTA-mPFC
projections elicits active coping in the tail suspension test (TST). Finally, I show using in vivo imaging of activity
that correlations between neurons fall over the course of active coping bouts, culminating in a transition to
immobility. These data suggest the main hypothesis of the proposed project, that passive coping results from a
breakdown of correlated activity and active coping is maintained by D2R-driven increases in correlations.
In aim 1, I will employ optogenetics to further define how phasic and tonic patterns of activity in VTA-mPFC
afferents influence different behaviors. In aim 2, I will use head-mounted miniscopes to confirm and expand
the initial finding that correlations degrade during struggling, imaging activity in D1 and D2R expressing
subnetworks. In aim 3, I will directly alter activity in elements of VTA-mPFC circuitry to establish causal
relationships between dopamine and circuit activity-behavior relationships. These results will establish a
foundation for my future work as this award allows me to start an independent laboratory.
In addition to conducting the proposed studies, I will be mentored towards independence by Dr. Vikaas Sohal
in whose laboratory this work will be accomplished. My scientific development will be aided by specific aspects
of the mentoring plan, including coursework, workshops, journal clubs and presentations at conferences. As a
physician, I will continue to expand my expertise in treating depression by learning cutting-edge techniques to
modulate activity in the brain. By the completion of the award, I will have obtained a professorship and
successfully applied for an R01 grant to launch an independent research program in neural circuits related to
mood disorders.

Public health relevance
PROJECT NARRATIVE The influence of dopamine on neural activity in the prefrontal cortex underlies cognitive and emotional functions that are frequently disrupted in psychiatric disorders. The goal of this project is to use light activated ion channels to release dopamine and miniature, head-mounted microscopes to directly observe the effects on prefrontal activity. This work will demonstrate the relationship of these activity patterns to distinct behaviors to determine processes that may be disrupted in disease states.